Prenatal Exposure to Organophosphate Ester Flame Retardants and Plasticizers (OPEs), Gene-Environment Interaction, and Child Neurodevelopment

ABSTRACT
The prevalence of autism and attention-deficit/hyperactivity disorder (ADHD) is increasing, yet their etiology is
poorly understood. A complex combination of environmental and genetic factors appears to contribute to both
conditions but most studies to date have examined these factors in isolation. The incomplete study of gene-
environment (GxE) interactions in autism and ADHD remains a significant barrier to progress in understanding
their etiology. Many endocrine-disrupting chemicals (EDCs) appear to be neurotoxic and their role in the
development of autism and ADHD merits closer scrutiny. Organophosphate ester flame retardants and
plasticizers (OPEs) are EDCs of emerging concern, with human exposures increasing rapidly when they
replaced polybrominated diphenyl ethers (PBDE) flame retardants starting in the early 2000s. Mounting human
evidence suggests that OPE exposure during pregnancy is detrimental to child neurodevelopment. Studies
specifically linking prenatal OPE exposure to autism and ADHD related outcomes are concerning; these
associations warrant closer examination. Notably, earlier studies of OPEs and neurodevelopment did not
consider genetic susceptibility, a concerning knowledge gap that potentially obscures subgroups more
sensitive to OPEs. Genetics may modify sensitivity to chemicals by shaping the efficiency of a person’s
metabolism of xenobiotics or making certain physiologic pathways more susceptible to exogenous disruption.
The proposed study seeks to build on this previous literature and further explore factors that modulate
sensitivity to prenatal OPE exposure in the context of child neurodevelopment. Specifically, we propose a
novel investigation of the genetic underpinnings of the association of prenatal OPE exposure and child autism
and ADHD using the rich and complementary data resources of two cohorts: 1) the diverse participant
population of the NIH Environmental Influences on Child Health Outcomes (ECHO) Cohort, which has a large
sample size and OPEs measured at one time point during pregnancy and 2) the Kaiser Permanente PETALS
cohort, a smaller, diverse cohort with OPEs measured at two pregnancy time points. Our overarching
hypothesis is that genetic variation across the genome, potentially in genes critical to neurodevelopment and
xenobiotic metabolism, may make some individuals more susceptible to OPE neurotoxicity during the prenatal
period. In Aim 1 we will perform a novel genome-wide by environment interaction study (GWEIS) of maternal
and child genetics and levels of urinary OPE exposure during pregnancy in relation to child neurodevelopment;
Aim 2 will harness polygenic scores (PGS) for autism and ADHD to examine modification of the OPE and child
outcomes relationship. In Aim 3, we will replicate and expand on findings from ECHO in the PETALS cohort.
The proposed work will lay the groundwork for continued study of GxE with respect to OPEs which could be
used to inform policies to protect susceptible subgroups and identify modifiable environmental risk factors to
lessen the disability associated with child autism, ADHD, and other neurodevelopmental conditions.

Public health relevance
NARRATIVE Elucidating how genetic and environmental factors interact has potential to improve our currently limited understanding of the etiology and rising prevalence of autism and attention deficit/hyperactivity disorder (ADHD). We propose a novel application of two genetic methods— a genome-wide by environment interaction study and polygenic scores— to study how maternal and fetal genetics may modify the association between prenatal exposure to organophosphate ester flame retardants and child neurodevelopment. This knowledge will ultimately lead to better identification of high-risk mothers and children and guide development of strategies to protect sensitive subgroups.